Mitochondrial Mechanisms Promoting Innate and Intestinal Immunity

Project Summary/Abstract: Inflammatory bowel disease (IBD) is largely characterized by dysregulated
cytokines and antimicrobial responses. Innate mechanisms are the initiating drives of host responses to
microbes and the resulting cytokine and antimicrobial responses need to be carefully balanced. Mitochondrial
pathways play a key role in mediating these innate responses and a dysregulation in mitochondrial
mechanisms has been increasingly recognized to play a role in IBD. The focus on the mitochondrial
dysregulation in IBD has been predominantly in epithelial cells. However, mitochondria contribute to innate
immune outcomes through a variety of mechanisms, including metabolic pathways, reactive oxygen species,
communication with the endoplasmic reticulum (ER), and mitochondrial DNA (mtDNA) release. Of the >240
IBD-associated loci a number of genes within these loci modulate host innate responses and mitochondrial
function through both direct and indirect mechanisms. As such, upon encounter of human macrophages with
microbial products, we have found IBD-associated genes that regulate glycolysis and in turn macrophage
polarization, the mitochondrial respiratory chain and mtROS, and ER stress. We further find that upon human
macrophage stimulation by a range of pattern recognition receptor (PRR) ligands, release of mtDNA is
dramatically increased along with activation of the cGAS- STING pathway. The cGAS-STING pathway then
serves to promote responses across the many PRRs. We have preliminary data that at least one IBD-
associated gene which partially localizes to the mitochondria, LACC1, modulates PRR-induced activation of
the cGAS-STING pathway, and in turn, downstream PRR-initiated downstream outcomes. We hypothesize
that the cGAS-STING pathway amplifies responses across a broad range of PRRs through a variety of
intracellular mechanisms, that the threshold of this regulation is important in susceptibility to intestinal
inflammation and might be therapeutically targeted under conditions of intestinal inflammation, and that IBD-
associated geneticvariants regulate these outcomes, thereby influencing key innate immune outcomes.
Relevance: These combined human cell and mouse studies will provide insight into mitochondrial
mechanisms regulating key outcomes in macrophages, the manner in which these mechanisms are altered in
IBD patients and in the context of IBD risk variants, and how these mechanisms might be modulated during
intestinal inflammation in order to improve outcomes in vivo. These comprehensive and mechanistic studies
will establish a foundation for additional studies to therapeutically target mitochondrialpathways shared across
innate immune responses so as to restore innate immune dysregulation.

Public health relevance
Project Narrative Dysregulated mitochondrial pathways have been increasingly implicated in inflammatory bowel disease (IBD), with the major focus being in the context of epithelial cells. We have observed that a number of IBD- associated genes regulate mitochondrial functions, which in turn, modulate key responses across a range of pattern recognition receptors (PRR) in macrophages. We will define mechanisms for mitochondrial contributions to PRR-initiated outcomes in human macrophages, determine roles for fine-tuning these outcomes in vivo in intestinal inflammation and infection, and establish how these mitochondrial functions are modulated by IBD-associated genetic variants and in intestinal tissues.